A CELLULAR BASIS FOR ATHEROSCLEROSIS IN HYPERTRIGLYCERIDEMIA

One R01 studies mechanisms of atherogenicity of triglyceride-rich lipoproteins (TGRLP) during the postprandial state in women and men, African-Americans and whites. One R01 focuses on characterization and cloning of the human monocyte-macrophage receptor for TGRLPs. Both study basic cellular mechanisms relevant to heart disease.